Local sleep and mental fatigue

Local sleep and mental fatigue
PROJECT SUMMARY
Mental fatigue—a feeling of exhaustion often accompanied by the sense that every task requires great effort—is prevalent in
neurological and psychiatric diseases. In healthy subjects, it is a common symptom ensuing after intense learning or sleep
deprivation. Mental fatigue is also frequent when sleep is poor and can be relieved by improving sleep quality. Moreover, the
broad cognitive impairment that accompanies mental fatigue is resolved by sleeping but not by resting while awake. Despite
the evidence linking mental fatigue with brain dysfunctions and sleep deficits, the reasons why the brain gets “tired” remain
unknown. This proposal tests a novel, circuit-level hypothesis about the neural mechanisms of mental fatigue caused by sleep
loss or intense learning. In these cases, we hypothesize that a key underlying mechanism is the increasing occurrence, within
corticothalamic networks, of local neuronal OFF periods in wake, triggered by the activation of Martinotti cells (MaCs). In
NIH-funded groundwork that led to this hypothesis we demonstrated, in both rodents and humans, that sleep deprivation leads
to “local sleep” in wake: even though the rest of the brain is awake, local groups of cortical neurons briefly stop firing (OFF
periods), as they usually only do, in a widespread manner, during sleep slow waves. Even though subjects are behaviorally
awake, if “local sleep” occurs in cortical areas involved in task execution, performance is impaired. In further work, we
demonstrated that the widespread OFF periods underlying the slow waves of sleep are promoted by the activation of MaCs,
which are somatostatin-positive (SOM+) GABAergic neurons found throughout cortex. Once recruited by strong excitatory
inputs from pyramidal neurons, MaCs can act as master regulators of cortical excitability by inhibiting all other cell types.
Finally, we found that extended wake and intense learning lead to increased neuronal excitability due to the progressive
strengthening of cortical glutamatergic connections, which are renormalized (weakened) by sleep and not simply by rest.
Guided by these findings and preliminary data, we propose that a key mechanism underlying mental fatigue is the increased
excitability of MaCs and their maladaptive triggering of OFF periods during wake. To test this hypothesis, we will perform
high-density Neuropixels recordings in mice and rats in multiple cortical and subcortical areas. These recordings will be
combined with optogenetic tagging to determine, first, whether extended wake or intense learning will activate MaCs and
trigger local OFF periods in wake. Guided by a new large-scale sleep/wake model of corticothalamic circuits, we will then
test two key predictions in vivo. Using opto/chemogenetics, we will determine whether, after extended wake or intense
learning, local OFF periods in wake are prevented by silencing MaCs and, conversely, whether they are triggered by the
activation of MaCs even in fully rested animals. If successful, we will uncover: 1) a candidate circuit mediating mental fatigue
after extended wake and intense learning; 2) a key mechanism through which fatigue is mediated—the induction of OFF
periods in corticothalamic networks due to the progressive build-up of synaptic strength in wake. Exploratory analysis of unit
data collected in thalamic, striatal, and hippocampal areas will also determine whether local sleep extends subcortically,
potentially contributing to the impairment in performance and motivation associated with mental fatigue.

Public health relevance
PROJECT NARRATIVE Mental fatigue—a feeling of exhaustion often accompanied by the sense that every task requires great effort—is prevalent in many neurological and psychiatric diseases. In healthy subjects, it is a common symptom ensuing after extended wake or intense learning. However, the reasons why we become mentally tired remain unknown. Based on recent findings, we hypothesize that a key mechanism underlying mental fatigue after sleep deprivation or intense learning is the increasing occurrence of brief, local periods of silence of brain cells. These “OFF periods” normally occur throughout the brain during sleep, but they can occur locally in wake (“local sleep” in wake) when we stay up for too long or engage in intense tasks. This project is relevant to public health because it will provide a mechanistic explanation of mental fatigue and its negative consequences. If successful, the proposed experiments will identify 1) a specific circuit of inhibitory and excitatory cortical neurons responsible for mental fatigue after extended wake or intense learning; 2) a neural mechanism underlying mental fatigue—the active induction of periods of silence in cortical neurons during wake. This project will also result in a large dataset of electrophysiological recordings from multiple areas of the brain. This dataset can be used in future studies to test whether, due to inflammatory or neuromodulatory changes, the neural circuit responsible for mental fatigue after extended wake or intense learning is also involved in pathological fatigue.